Role of Class IIa HDACs HDAC4 and HDAC7 in Pathogenic Th17 Cell Development and Colitis

PROJECT SUMMARY
Alzheimer's disease (AD) is the most prevalent neurodegenerative disorder of aging. The major pathological
hallmark of AD in the brain amyloid plaques consists of amyloid β peptide-40 (Aβ40) and peptide-42 (Aβ42) that
are produced from amyloid precursor proteins by sequential cleavage. However, nearly all experimental drugs
targeting Aβ cleavage and processing tested for AD have failed to show significant efficacy. Alternative
therapeutic options are being explored, as accumulating evidence has indicated that Aβ accumulation alone
cannot explain much of the pathogenesis of AD, indicating the involvement of other pathological processes.
Notably, neuroinflammation has emerged as a key player, as it is initiated by amyloid plaques, followed by
activation of microglia and inflammatory CD4+ T-helper 17 (Th17) cells that eventually leads to
neurodegeneration in the brain. This process is fueled by Th17-secreted inflammatory cytokines IL-17, IL-21,
IL-22, IL-23, IFN-g and GM-CSF that are found to be elevated in AD patients. We recently discovered that
Class IIa HDACs are essential for Th17 cell differentiation, but not Th1, Th2, and Treg subtypes that have
different functions in immunity. Specifically, using genetic knockout mice, we found that Hdac4 activates gene
transcription of Th17 cytokines IL-17A and IL-22 while Hdac7 represses gene transcription of Th17 negative
regulators IL-2 and IL-10. Chemical disruption of HDAC4/7 by TMP269 attenuates inflammatory cytokine
production by pathogenic Th17 cells and blocks Th17 over-development in experimental autoimmune
encephalomyelitis (EAE) mice model and attenuates cognitive impairment in a mouse model of AD.
Collectively, our results suggest that Class IIa HDACs are attractive new targets for neuroinflammation in AD.

Public health relevance
PROJECT NARRATIVE This project aims to evaluate in-vivo therapeutic efficacies of Class IIa HDAC inhibitors by behavioral studies and characterization of therapeutic mechanisms in ApoE4+/+;5xFAD+/- (E4FAD) mice, a mouse model of Alzheimer’s disease. The outcome will empower the research community to better understand the how we can target Class IIa HDACs to control Th17-mediated neuroinflammation, which will have great implications in human health, aging-related neuroinflammation and Alzheimer’s disease.